Integrating frequency and phenotypic association data to improve interpretation of rare genetic variants

PROJECT SUMMARY/ABSTRACT
At present, the diagnoses of many rare disease patients remain unsolved and the effects of rare variants in
common diseases remains unclear. Further, the phenotypic effects of most high-impact mutations are unknown.
Accurate methods to interpret genetic variants would enhance many aspects of biomedical research, including
genome-wide association studies and functional studies, as well as clinical diagnostics of rare disease patients.
In my laboratory, we build tools, methods, and resources to interpret genetic variation that are applicable in
clinical practice and human disease research. Beginning with predicted loss-of-function variants, we have built
a widely used annotation tool, LOFTEE, that is highly specific in identifying variants triggering nonsense-
mediated decay. I have aggregated massive datasets of human genomes and exomes (gnomAD) to build the
largest variant frequency maps released to the public, for clinical laboratories and researchers interpreting
disease variation. Finally, I have performed massive-scale common and rare variant association analysis on
thousands of phenotypes using mixed models to describe the most robust estimates of variant-phenotype
associations, powering gene discovery for common diseases. Using state-of-the-art computational methods, this
research program will improve the interpretation of variants in the human genome, improving current annotation
methods for predicted loss-of-function, missense, and non-coding mutations, incorporating information from
genetic reference data as well as biobanks with genome and disease/phenotype data. My research program will
build a framework for assessing function for many classes of deleterious variants by integrating frequency data
from diverse populations into deep learning frameworks. Finally, this project will integrate rare variant association
data into deep learning models to identify loss-of-function-like missense variants. In this way, my research
program will improve interpretation of genetic variants found in patients and large cohorts and biobanks,
improving clinical genetic practice and human disease research.

Public health relevance
PROJECT NARRATIVE Millions of people are having their genomes sequenced as part of common disease studies and in direct healthcare settings, but interpreting the variants identified in their genomes remains a significant challenge. This project will develop statistical and deep learning methods to accurately interpret genetic variation in order to improve diagnosis of rare disease patients and provide insight into the function of human genes and their role in human disease.